Florida Regional Coordinating Center for the NINDS Stroke Trials Network

PROJECT SUMMARY: Florida Regional Coordinating Center for the NINDS Stroke Trials Network This proposal outlines the University of Miami’s application to remain as the Florida Regional Coordinating Center (RCC) in the Stroke Trials Network (Stroke Net). The goals of the Florida RCC are to: a) provide a robust and efficient infrastructure to implement high-quality research clinical trials that address acute stroke treatment, prevention, and recovery; b) leverage the internal and regional resources to enhance the Stroke Trials Network; c) train the next generation of stroke clinical and translational researchers and enhance the careers of research personnel. The Florida RCC encompasses a large network of participating acute stroke, rehabilitation and pediatric hospitals that span across Florida, and is designed to ensure robust enrollment of an ethnically diverse population that reflects the changing demographics of the US. Our RCC has a successful track record of enrollment in numerous NINDS acute and secondary prevention stroke trials and is involved in other NIH networks and coordinates multicenter studies. Through our participating sites, extended referral network, and multidisciplinary expertise, we will build upon the close partnership with pre-hospital Emergency Services, Emergency Medicine, Vascular Neurosurgery, Interventional Neurology, Neuro-Critical Care, Pediatric Neurology and Neurorehabilitation, as well as on academic-public-private institutional collaborations, to enroll and manage potential study participants. We also have unique resources that we can bring to the network. Integrated collaboration among cutting-edge researchers in the areas of preclinical stroke, stem cells, human genomics, biorepository, brain bank, and the Miami CTSI make us uniquely positioned to develop, propose and implement novel translational early-phase projects. The large residency and fellowship training programs in Neurosciences, the multidisciplinary educational resources in the institution, and our track record of mentoring clinical researchers, position our center to effectively train stroke researchers in clinical and translational research through a structured mentored program. In this cycle, we will also implement a robust career enhancement program for research personnel to maintain and expand research expertise. Over the past funding cycle, we have been an outstanding Stroke Net member: we were the highest enrolling RCC in the network, we expanded the RCC representation across Florida by adding new outstanding sites, trained 4 Stroke Net scholars, participated in 3 working groups and committees, submitted new proposals to the Network, and were engaged in all aspects of the program. Therefore, we have the depth and breadth of expertise and resources to successfully function as a RCC in the Stroke Net.

Public health relevance
The Florida Regional Coordinating Center will provide access to unique research resources in the areas of preclinical stroke, stem cells, human genomics, and biorepositories that can be leveraged across the network. Through its educational and research opportunities, it will train and enhance the careers of the next generation of stroke clinician scientists and research experts to preserve and expand stroke research expertise.